Somatic inactivation of the SNCA locus: a new approach to the understanding and treatment of Parkinson's Disease

? DESCRIPTION (provided by applicant): Parkinson's disease is the second most prevalent neurodegenerative disorder in the United States. A continued lack of curative treatments poses a burden not only to PD patients but also to our society as a whole. Thus, the development of disease modifying therapies is imperative. This will require paradigm-shifting strategies designed to modulate, not the cause of symptoms, but the molecular underpinnings driving neuronal dysfunction in the PD brain. Numerous genetic and biochemical studies firmly place the SNCA gene, which encodes for a-synuclein, at the center of the patho-molecular events driving onset and progression of genetic and sporadic forms of PD. Aberrantly polymerized forms of a-synuclein are the major component of Lewy bodies and Lewy neurites that are classically observed in PD. Also, a-synuclein inclusion pathology tracts with the neuronal degeneration that is observed in PD. Moreover, recent studies have suggested that a-synuclein fibrils could act in a prion-like mechanism to seed and spread a-synucleinopathy throughout, perhaps underlying the toxicity observed in PD and other forms of dementia. Because a-synuclein-induced pathology requires sustained a-synuclein expression, it is hypothesized that curtailing SNCA expression could impede the onset or progression of disease. Here, we propose to investigate the feasibility of a novel, paradigm- shifting gene targeting approach to inactivate the SNCA gene in somatic brain tissue. Experiments in aim-1 of this proposal will develop, test and determine whether adeno-associated virus (AAV)-delivery of a new CRISPR/Cas9 system into adult mammalian brain results in safe and effective inactivation of the SNCA locus. Results from this first set of experiments are expected to validate AAV-CRISPR/Cas9 as a novel, powerful tool that can be used by the entire neurodegenerative disease research community to query gene function in the brain. Proof-of-principle studies in aim-2 of this proposal will determine if AAV-CRISPR/Cas9-mediated inactivation of SNCA in a novel mouse model of a-synucleinopathy is efficient enough to modify the onset or progression of a-synuclein pathology in disease relevant areas of the brain. Results from these experiments are anticipated to provide the basis for further development of this novel molecular therapy for PD and other incurable neurodegenerative diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is an unmet need for the development of therapies that can modify the onset and progression of Parkinson's disease (PD). Seminal studies in patients and model systems firmly place the SNCA gene, which encodes for a-synuclein, at the center of the complex, toxic molecular events that result in PD. The proposed studies aim to develop a novel, paradigm-shifting strategy to inactivate genes that, like SNCA, appear to play an essential role in driving onset and progression of neurodegenerative disease. The approach relies on the use of adeno-associated virus (AAV) as a vector to deliver the gene editing/targeting CRISPR/Cas9 system into the CNS. The goal of these studies is to validate the AAV-CRISPR/Cas9 gene inactivation approach as a powerful tool for the study of gene function in the brain. Moreover, results from these studies could provide the basis for the development of this strategy as a novel therapeutic approach to PD and similar neurodegenerative disorders.